Mechanism-informed design of allosteric protein sensors

PROJECT SUMMARY
The overall vision of our research program is to deeply understand how proteins occupy an ensemble of
conformations to enable biological functions, towards computationally designing new, functional protein
ensembles from scratch. Designing protein ensembles that sense and respond to environmental perturbations
represents a major challenge in biophysics. However, natural proteins have evolved many mechanisms for
sense/response behavior, often without requiring dramatic changes to the protein’s average structure, and in the
context of protein folds that are strongly conserved across kingdoms. We do not generally understand how
natural protein ensembles are conserved and repurposed for diverse functions while maintaining relatively few
protein folds because we have few strategies to determine the energetic contribution of every amino acid in a
protein to a global conformational change. Understanding the energetics of protein ensembles of all sizes in
solution at high resolution would enable a deeper familiarity of how natural sense/response behaviors evolved.
Quantitative descriptions of how proteins shift conformations to respond to perturbations would then inform
design constraints to guide efforts in reengineering natural protein sensors for functional responses to
environmental signals.
In the next five years, we plan to develop a new way to understand how natural proteins behave as small
molecule sensors and reengineer them to respond to user-defined ligands. First, we will establish and benchmark
a method to determine the contribution of each amino acid in a protein to its folding and binding Gibbs free
energies from medium-resolution hydrogen-deuterium exchange/mass spectrometry (HDX/MS) data. HDX/MS
is a powerful technique to assess protein ensembles in solution. Building on our recent work to solve the
mechanism of ligand-driven allostery in a dimeric bacterial transcription factor, we will then apply our method to
quantitatively understand how other members of this ancient protein family respond to small molecule ligands,
as well as monomeric proteins with the same fold. This work will expand our understanding of the evolution of
allosteric conformational changes and oligomerization in this protein fold and provide a detailed roadmap for
computationally redesigning these as protein sensors. We then propose to redesign the transcription factors as
small molecule sensors in accordance with the energetic requirements for functional response in the family as
determined in by HDX/MS using physics-based and machine learning computational methods for two
applications: (1) transcriptional regulators in bacteria for biological upcycling of poly(ethylene-terephthalate)
plastic waste, and (2) human cell membrane receptors for metabolite sensing in the solid tumor
microenvironment.

Public health relevance
PROJECT NARRATIVE Natural proteins function as “sensors” by binding ligands to shift their global conformational ensembles into new functional states, but it remains challenging to design this behavior from first principles because we do not know how each amino acid contributes to the energy of each state. We propose a new method to determine high- resolution energetic information from hydrogen-deuterium exchange / mass spectrometry experiments to investigate the evolution of natural protein sensors with the common Venus Flytrap (VFT) fold. We plan to apply this knowledge to engineer artificial VFT-fold protein sensors for applications in sustainable plastic upcycling and cell therapies to treat solid tumors.